Center for Biomedical Research Excellence, Epigenomics of Development and Disease

University Of North Dakota
Epigenomics of Development and Disease
OVERALL
SUMMARY
The goal of this COBRE 3 application is to continue to sustain research in epigenetic mechanisms underlying
development and disease at the University of North Dakota by providing ongoing support to the Epigenetics
Working Group (EWG). In COBREs 1 and 2 the EWG made significant progress towards development of an
epigenetics/epigenomics program through support of individual projects, building our core group by recruitment
of epigenetics experts, and supporting faculty development through mentoring and accountability programs. We
established a comprehensive Genomics Core to meet the needs of the epigenetics community and provided
technical and financial support that increased the number of researchers in our community utilizing epigenetic
approaches. In Phases 1 and 2, our COBRE Investigators made important discoveries that resulted in 64 papers
published in high impact journals, 152 poster and oral presentations by Project Leaders at invited seminars or
scientific meetings, and the awarding of more than $26 million in external funding from R01, R21, DoD, NSF and
foundation grants.
In this proposal, we seek to maintain this momentum and transition our group towards sustainability through the
following strategies: (1) Promote high-quality research, expand the reach of the group through collaborations
with experts in other fields, and support innovative, cross-disciplinary research through a Pilot Project Program;
(2) Supporting the Genomics Core to enable performance of cutting-edge research, and empower researchers
through training and educational workshops in bench and computational epigenetics; and (3) Promote long-term
sustainability of the group through building partnerships with other IDeA state groups and cohorts and expanding
expertise to other fields such as clinical/translational science and Artificial Intelligence. Our long-term goal is to
transition the EWG into a sustainable scientific center dedicated to understanding molecular mechanisms of
developmental and pathological disorders that will attract top talent, train the next generation of scientists, and
become a national hub for cutting edge epigenetics research.

Public health relevance
University Of North Dakota Epigenomics Of Development and Disease OVERALL PROJECT NARRATIVE The goal of this project is to facilitate the growth and sustainability of our Center of Biomedical Research Excellence “Epigenomics of Development and Disease” at UND. This will be achieved by supporting (1) a Pilot Project Program focused on epigenetic mechanisms in development and disease to bolster collaborative research, (2) a Genomics Core providing infrastructure and technology essential to our group and the wider research community, (3) an Administrative core to provide educational, oversight, and faculty development programs. These endeavors are poised to strengthen our group and enhance our ability to perform cutting- edge research with direct relevance to human health in the context of epigenetic mechanisms in disease and development.